Exploring the Attitudes, Barriers, Concerns, Differences, and Ethics (ABCDEs) of Healthcare Decision Making in Prospective Peripheral Indications for Vagus Nerve Stimulation Patients

The NIH Stimulating Peripheral Activity to Relieve Conditions (SPARC-V) initiative will primarily focus
on cervical vagus nerve stimulation (VNS). Despite VNS achieving its first Food and Drug Administration (FDA)
clearance in 2001 in drug resistant epilepsy and a second indication in difficult to treat depression in 2005,
VNS has made minimal public health impacts. Over 125,000 individuals are utilizing clinical VNS. This
relatively low uptake in proportion to the size of the population eligible for VNS suggests patients perceive VNS
poorly or have unaddressed ethical concerns regarding this technology. VNS is a unique form of invasive
neuromodulation requiring a VNS therapy pulse generator to be surgically implanted in the chest wall and a
tunneled electrode that delivers intermittent electrical stimulation to the vagus nerve. VNS differs from other
forms of electrical neuromodulation uniquely in its invasiveness. Compared to electroconvulsive therapy (ECT)
and deep brain stimulation (DBS) in that it indirectly affects the brain through a cranial nerve rather than
cortical stimulation so it does not require craniotomy like the latter. Additionally, adequate VNS therapy
response is delayed compared to other forms of electrical neuromodulation with ECT inducing response in the
order of 1 mo and DBS inducing motor response as early as the same day of device activation. The protracted
response trajectory generates ethical issues in neuromodulation particular to this technology deserving of
further consideration in order to understand VNS healthcare decision making.
REVEAL/SPARC-V offers a unique opportunity to observe a large population anticipating implantation
with VNS. The study will recruit adults seeking VNS therapy for both epilepsy and difficult to treat depression
and observe them after implantation to characterize VNS’s effects on peripheral systems such as the
cardiovascular, immunologic or metabolic systems in addition to their clinical response. These patients offer a
unique opportunity to characterize previously unexamined ethical issues and perceptions of VNS while the
technology is poised to be developed for additional peripheral indications.
We propose a mixed-methods evaluation to characterize VNS specific ethical factors that can impact
VNS acceptability for its current indications and to proactively assess these factors for emerging indications in
peripheral disease states. After a series of development focus groups a semi structured interview phase
assess VNS ethical considerations in depression, epilepsy and prospective peripheral indications in groups of
physicians, patients and their caregivers and perform thematic analysis. Additionally, we will use survey
methods to assess perceptions of stigma, acceptability, risks,benefits,invasiveness, and barriers to care
(defined as medical decision metrics). This work will crucially contribute to the under-examined ethics of VNS.
Our proposal will set the stage for better adoption of VNS for both central nervous system illnesses and
peripheral organ diseases.

Public health relevance
The propose a mixed-methods project aimed at exploring the health care decision making process of prospective VNS patients recruited for the parent award. We will develop semi-structured interviews from focus group data to gather and characterize common attitudes, barriers, concerns, differences, and ethical concerns around VNS within groups of clinicians, epilepsy and depressed patients, and caregivers to understand how acceptance develops. This research will produce a unique dataset showing common themes and ethical concerns central to the acceptability of a treatment poised to have rapid expansion to new diagnoses.